EFFECTS OF SLEEP DEPRIVATION ON RECOVERY AFTER ANESTHESIA IN HEALTHY VOLUNTEERS

Our hypothesis is that sleep deprivation will lengthen recovery after anesthesia. Ample evidence exists to show sleep deprivation affects performance; no study has examined the effect of sleep deprivation on performance after anesthesia. 12 subjects will randomly either sleep a full night or be awake all night; and will either receive brief anesthetic or no anesthetic. Afterwards, psychomotor performance will be measured.